Neural sensitivity to social evaluation and daily online and in-person social experience with peers: Predicting fluctuations in suicidality, self-harm, and depressive symptoms in adolescent girls

PROJECT SUMMARY/ABSTRACT
Rates of suicide, self-harm, and depression are alarmingly high among adolescent girls, with a dramatic spike
over the last decade, yet it is not clear which girls are at highest risk for these serious problems and when they
might escalate. Some have argued that the dramatic rise in social media (SM) use may play a role, but more
rigorous data are needed to evaluate the positive and negative effects of SM use in adolescent girls. Sensitivity
to social evaluation, such as rejection or exclusion, is a potential cross-diagnostic risk factor for self-injurious
thoughts and behaviors (SITB; including suicidal ideation and behavior and nonsuicidal self-injury) and de-
pressive symptoms (DEPsx). This study examines how socially threatening and rewarding peer interactions—
experienced online or in-person—contribute to real-time fluctuations in SITB, DEPsx, and well-being. The first
aim is to use ecological momentary assessment (EMA) to identify how adolescent girls’ daily subjective experi-
ence of online and in-person social threat and reward predict proximal within-person changes and longer-term
between-person differences in SITB and DEPsx, along with wellbeing. The sample will include 177 adolescent
girls (ages 13-17), with 75% of the sample at high-risk for suicide (e.g. active ideation within past 6 weeks, at-
tempt in past year, or ≥ five episodes of nonsuicidal self-injury in past year), with at least half of high-risk par-
ticipants also reporting elevated DEPsx. Girls will complete three 10-day bursts of EMA and will also provide
access to passively obtained data on SM use and digital social interactions (i.e. text, video-chat). Multilevel
modeling analyses will be used to identify predictors of near-term changes in SITB, DEPsx, and positive affect
(PA), as well as long-term outcomes assessed at 6- and 12-month follow-up. A second aim is to identify which
girls are at highest risk for DEPsx and/or SITB when exposed to near-term precipitants, focusing on differences
in brain activation to social evaluation within an affective salience network (ASN) that includes the amygdala,
anterior insula, dorsal and subgenual anterior cingulate cortex, and nucleus accumbens. Building on the differ-
ential susceptibility to context theory, the study proposes that heightened ASN activation to social evaluation is
a susceptibility factor that could amplify both the positive and negative effects of daily social experience on
SITB and DEPsx. Girls will complete neuroimaging tasks that assess brain response to social evaluation from
virtual peers. It is hypothesized that within-person increases and higher rates of peer social threat experiences
(online and in-person) will be most strongly associated with SITB and DEPsx for girls with heightened ASN
activation to social evaluation, and that within-person increases and higher rates of peer social reward experi-
ences will also be more strongly associated with PA/wellbeing and more protective against SITB and DEPsx for
girls with heightened ASN activation to social evaluation. Finally, machine learning will be used to determine
which objective features of SM use track in real-time with subjective experience and emotional health, and to
identify the strongest set of predictors of short-term and long-term emotional health.

Public health relevance
PROJECT NARRATIVE Results from this study could help address the current mental health crisis among adolescent girls by leverag- ing real-time data to identify near-term risk factors that more optimally predict when girls will experience esca- lations in suicidality, as well as common earlier precursors to suicide such as nonsuicidal self-injury and de- pressive symptoms, and leveraging neuroimaging data to identify which girls may be at highest risk. This infor- mation is critical for improving real-time risk detection, designing just-in-time suicide prevention and inter- vention approaches, and accelerating the discovery of potential neural markers of risk and/or protection from these serious emotional health problems. Additionally, the study will provide rigorous empirical data on the real-time positive and negative links between social media use and adolescent emotional health that can inform public perceptions and policies surrounding social media use among adolescents.